Sex differences in operant cocaine memories

The inability to maintain abstinence is a trademark of addiction yet effective maintenance therapies
remain elusive. Women may face unique issues with substance abuse treatment, as research indicates
that psychological and biological responses to drugs of abuse differ in women compared to men. Women
tend to show greater drug dependence, progress more quickly from casual drug use to dependence, have
greater difficulty quitting, and have shorter periods of abstinence than men. These effects have been
similarly observed in female animal models. Thus, understanding circuit and molecular signatures that
drive increased drug-seeking among females is critical to the development of effective SUDs therapies.
We have developed a novel behavioral model termed the seeking-persistence paradigm (SPP) that was
adapted from standard drug abstinence paradigms. The seeking-persistence paradigm is used to
investigate the influence of intervention during initial abstinence on long-term drug-seeking behaviors.
Indeed, cocaine-seeking during initial abstinence strongly correlates with seeking after drug-abstinence.
These results reflect clinical studies indicating that craving during initial abstinence predicts relapse rates.
We have previously identified that the dorsal hippocampus is a crucial target for sex-specific modulation of
cocaine-seeking on ED1. Prior reports show projections from the dorsal hippocampus selectively
modulate memory strengthening or facilitate extinction, dependent on whether they terminate in the
prelimbic cortex, or infralimbic cortex, respectively. Our preliminary data suggest that sexually-divergent
projections of the dHPC to prelimbic and infralimbic cortical areas may underlie sex differences in
persistent cocaine seeking during extinction. Herein, we will test the hypothesis that
hippocampal-prelimbic cortex neurocircuitry drives the behavioral expression of cocaine memory
strengthening in female rats (Aim 1), and hippocampal infralimbic cortex neurocircuitry drives the
behavioral expression of cocaine memory extinction in male rats (Aim 2). In each aim, we will combine
chemogenetic (DREADDs), and functional genomic methods (viral tracing, RNA-sequencing, and
single-cell RNA-sequencing), to ultimately provide key information on the impact of context-induced
cocaine seeking behavior on relapse risk through the novel analysis of the contribution of memory
systems (dHPC ->PL, dHPC-> IL) and sex differences therein.

Public health relevance
Individuals suffering from substance use disorders are susceptible to relapse when presented with contextual cues, suggesting that contextual memories associated with drugs of abuse impede abstinence success. Developing effective treatments to assist with maintaining abstinence is a significant challenge, complicated by unique, sex-dependent responses to drugs of abuse in women compared to men. Thus, understanding sex differences in neural circuitry driving contextual drug memories is critical to the